UCLA Neuroscience Physician-Scientist Training Program

ABSTRACT
Physician-scientists occupy a critical niche in the translation of basic science findings into new clinical treatments.
Within the field of neurology and neurosurgery, physician-scientists have been at the forefront, among many
examples, in developing new models of human disease, developing new clinical treatments for Parkinson's
disease, epilepsy and stroke, identifying novel genetic signatures of brain tumors, glial progenitors and neural
stem cells that may facilitate new therapies. However, the relative and absolute numbers of physician scientists
have been declining over the past 25 years, despite the doubling of the NIH research budget during a portion of
this epoch. This is in large part due to the prolonged nature of the training for a physician-scientist. The NIH has
recognized this problem in the release of this RFA for Research Education Programs for Residents and Fellows
in Neurology, Neurosurgery, Pediatric Neurology, Neuropathology, Neurogenetics, Neuroradiology and
Emergency Medicine. The goal of the UCLA Neuroscience Physician-Scientist Training Program in this grant
proposal is to train residents in either basic or clinical science research through direct investigative study, oral
and written scientific presentation and intensive mentored career development. The structure of the training
program incorporates several tiers of mentoring and focused time on oral and written presentations, with a
culmination in the production of career development grant. This training program is supported by an excellent
environment for neuroscience research and education on the UCLA Campus. The UCLA Neurology department
has been a top ten NIH funded neurology department with a large clinical and basic research faculty with diverse
and well-funded programs. Similarly, the UCLA Department of Neurosurgery has consistently been in the top 5
NIH-funded neurosurgery departments in the nation, and has a significant depth and breadth of clinical,
translational, and basic research faculty with diverse and well-funded subspecialty programs. Both core
residency programs are large with the flexibility to place selected residents in a research program, and both have
a track record of training many academic neurologists and neurosurgeons. The proposed education program
takes advantage of the substantial neuroscience community within the Neurology and Neurosurgery
Departments and allied departments to have a large and scientifically diverse group of mentors with great depth
of research and past training experience. By serving to integrate clinical and basic neuroscientists with residents
in the context of their clinical training program, this grant maintains and develops a UCLA Neuroscience
Physician-Scientist Training Program that will ensure the next generation of highly trained neurologist- and
neurosurgeon-scientists will be available to make future advances to lessen the burden of neurological diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE Physician-scientists have an important role in developing new therapies for disease, yet the numbers of physician and surgeon-scientists have been declining in recent years. This grant develops a research program to train physician-and surgeon-scientists with a background in neuroscience to tackle the most pressing diseases affecting the nervous system. This program will use an innovative pathway of laboratory or clinical research training, close mentoring and didactics in grant writing, and training in research ethics to advance a new generation of diverse independent physician-scientists who can further our understanding of the mechanisms, etiology, and treatment of neurological diseases. .